Multiscale modeling of spatiotemporal evolution in Barrett's esophagus

PROJECT SUMMARY
The practical goal of this project is to obtain high-resolution genetic and epigenetic maps that reveal the
evolutionary relationships and dynamics over space and time in Barrett’s esophagus (BE). Barrett’s is the
precursor to esophageal adenocarcinoma (EAC) therefore patients undergo surveillance exams to detect early
cancers. Our study will provide an unprecedented level of molecular detail that has not been achieved in any
previous study of pre-cancer evolution in BE. Importantly, the proposed experiments and analyses will define a
BE patient’s “tissue phylogeography”, including significant features of clonal expansions that are predictive of
BE progressing to future EAC. To this end, we will leverage a rich set of serially collected tissue samples and
genomic data from patients in the Seattle BE natural history cohort that includes cancer outcome patients and
an age-matched group of patients with non-cancer outcomes, sampled at multiple time points. The unique
design of this case-control study enables us to identify (epi)genetic markers prognostic of progression using
data from advanced multi-omic platforms. Computational modeling and phylogenetics will be used to extract
the elusive but essential information on when BE arises in a patient, how fast particular clones spread in BE,
and how dispersive these clones are within the tissue. Ultimately, we will use these evolutionary quantities to
forecast outcomes of cancer versus non-cancer in a well-documented prospective patient population.
The long-term goal of the project is to assess the feasibility and performance of data-driven predictive models
that can be translated to improved clinical care. Notably, this project will quantify the utility of robust molecular
markers for EAC risk to improve the current practice of relying solely on histopathologic features that are
difficult to assess and interpret. To facilitate this goal, we will parameterize the inferred space-time dynamics in
phylogeographic reconstructions of this pre-cancer, and embed these measurements in a multiscale model
framework for progression from BE to EAC in a population. This multiscale approach explicitly models the
stochastic clonal expansions at the cellular level over a patient’s lifetime, within the spatial constraints of the
esophagus. The three specific aims for our project are: 1) Measure how new clones arise and spread within
Barrett’s glands; 2) Measure how glands move and grow through the Barrett’s lesion by quantifying epigenetic
drift to estimate Barrett’s tissue age and constructing phylogeographies to infer how Barrett’s clones spatially
evolve; and 3) Integrate spatiotemporal measurements from multi-region Barrett’s samples into a multiscale
model of EAC development. The proposed project is innovative because we will infer evolutionary parameters,
such as rates of stem cell replacement and TP53 two-hit inactivation in BE, from (epi)genomic data for the first
time. This research is significant because it is expected to provide predictive models that incorporate dynamic
biomarkers of EAC progression in BE patients to potentially offer new strategies of risk-based surveillance.

Public health relevance
PROJECT NARRATIVE Patients diagnosed with Barrett’s esophagus have a more than 30-fold higher risk of developing esophageal adenocarcinoma (EAC) than the average person, and thus are advised to undergo follow-up examinations for early detection of EAC when it can be removed. With current clinical measurements, however, it is impossible to discern which patients are most likely to develop EAC versus the >90% who will never get this rare but deadly cancer. In efforts to solve this public health question, we aim to interrogate the entirety of Barrett’s tissue, measure how it evolves over time in patients, and look for clues in these “tissue maps” to better decide who needs preventative action and who can live their life with less worry and intensive surveillance.